Investigating the role of lipid metabolism in the biogenesis of lysosome-related organelles

Project Summary:
Investigating the role of lipid metabolism in the biogenesis of lysosome-related organelles
Lysosome-related organelles (LROs) are cell type-specific compartments that share characteristics with
ubiquitous conventional lysosomes, yet have specialized functions. LROs are evolutionarily conserved
derivatives of the endosomal system that include mammalian melanosomes and platelet dense granules, gut
granules in C. elegans, Drosophila pigment granules, and acidocalcisomes in protozoan parasites. Defective
LRO biogenesis leads to Hermansky-Pudlak (HPS) and Chediak-Higashi (CHS) syndromes, which cause
partial albinism and delayed blood clotting. It is surprising how little attention has been focused on processes
controlling LRO size and shape, given how tied LRO morphology is to mechanisms controlling LRO
biogenesis, homeostasis, and function. Enlarged LROs are pathogenic in CHS and are diagnostic of HPS1,
the most common form of HPS. Prior approaches to identify factors involved in LRO biogenesis have not been
designed to identify factors regulating LRO morphology. LRO morphology is controlled by the interplay of
membrane trafficking to and from LROs as well as LRO fission and fusion, processes fundamental to the
biogenesis, behavior, and activity of LROs. Identifying and characterizing the activity of conserved genes that
impact LRO morphology will likely lead to new insights into the processes regulating LRO biogenesis.
The goal of this project is to gain a better understanding of the processes controlling LRO morphology by
studying acdh-11, which we identified in a screen for mutants that disrupt the morphology of C. elegans LROs
called gut granules. ACDH-11 is a highly conserved member of the medically important acyl-CoA
dehydrogenase (ACDH) family that catalyze the beta-oxidation and catabolism of fatty acids and amino acids.
Our work showing acdh-11(-) mutants cause gut granule enlargement identifies a novel role for an ACDH
protein. The FAT-7 fatty acid desaturase becomes expressed and is in part required for LRO enlargement in
acdh-11(-) mutants. FAT-7 catalyzes the creation of unsaturated fatty acids, which can promote membrane
fluidity by disrupting lipid packing. Our results support the possibility that changing the physical characteristics
of membranes influences membrane dynamics to increase gut granule size. The mechanisms by which ACDH-
11 and FAT-7 function to impact LRO size is investigated through four specific aims: (1) investigate how
ACDH-11 impacts gut granule size by defining where ACDH-11 acts and whether it functions enzymatically or
as a sink for fatty acid substrates; (2) test whether FAT-7 causes the enlargement of gut granules in acdh-11(-)
mutants by increasing unsaturated fatty acids within the membranes of intestinal cells; (3) analyze whether gut
granule enlargement in acdh-11(-) results from increased membrane fluidity; and (4) identify other genes and
pathways acting in acdh-11(-) to promote gut granule enlargement and FAT-7 expression. This work explores
novel roles for an acyl-CoA dehydrogenase and fatty acid desaturase in organelle size and furthers our
understanding of how lipids contribute to the formation and homeostasis of LROs.

Public health relevance
Project Narrative Many human diseases are caused by aberrant lipid composition and rarely do we understand the mechanisms leading to the disruption of normal physiology. The C. elegans proteins being studied are homologous to human proteins that function in lipid metabolism. The proposed work will provide insights into how alterations in lipid biosynthesis and degradation can disrupt cellular physiology, which will provide fundamental knowledge that could lead to the treatment of disease.